Cognitive, Immunological, and Neurophysiological Consequences of Home Radon Exposure in Children and Adolescents

Project Summary/Abstract: Research Project (1)
Cognitive, Immunological, and Neurophysiological Consequences of
Home Radon Exposure in Children and Adolescents
The public at large has grown keenly aware of the effects of environmental pollutants and toxins on the
developing body. From lead and pesticides to cigarette smoke and industrial air pollution, studies consistently
show that environmental toxins have substantial, lasting impacts on the development of youth, including chronic
deficits in cognitive and brain development. These consequences can have reverberating impacts on academic
achievement and mental health. That said, one surprisingly common, but rarely studied environmental toxin is
radon. Radon is a naturally occurring radioactive gas that accumulates in homes and poses significant health
risks, including increased risk of developing certain cancers, and damage to developmentally sensitive tissues
and organs (e.g., the brain) through accentuated inflammatory processes. The United States (US) Environmental
Protection Agency (EPA) set the action limit for home radon concentrations at 4 pCi/L, which is the carcinogenic
equivalent of smoking 10 cigarettes per day. An astonishing 1 in 15 homes across the US is expected to have
radon concentrations at or above the EPA action limit, leaving a large number of youth across the country
chronically exposed to high concentrations of radon. However, studies linking radon toxicity to altered neural and
cognitive development are extremely sparse. The current proposal aims to address this critical gap in knowledge
by examining the impact of toxic levels of radon exposure on brain and cognitive function in typically-developing
youth. Our groundbreaking preliminary work is the first to show that attention (i.e., the ability to direct and maintain
focus on specific stimuli and tasks) is uniquely impacted by radon exposure. Specifically, we have found that
youth who are chronically-exposed to higher home radon levels had markedly worse performance on behavioral
measures of attention, and exhibited altered neural dynamics within the critical brain networks serving attention
and higher-order cognition. In the current multimodal neuroimaging study, we will quantify the impact of home
radon exposure on multiple distinct attentional systems during child and adolescent development. To this end,
we will enroll a large sample of typically-developing youth who will undergo magnetoencephalography (MEG)
during a battery of tasks designed to assess multiple unique neural systems serving attentional processing.
Youth will also complete structural magnetic resonance imaging (MRI), complete a battery of neuropsychological
assessments targeting attentional abilities, and provide saliva samples to capture measures of inflammation that
are known to be elevated in the context of radon exposure. Our specific aims are to 1) identify specific attentional
domains and neural substrates that are affected by radon exposure, and 2) quantify the mechanistic role of
inflammatory processes through which radon alters attentional development in youth. The outcomes of this study
have the potential to shape the future of public health policy surrounding radon awareness and mitigation efforts,
and this is especially true in the surrounding region where home radon levels are some of the highest in the nation.